Basal Ganglia Network Neurophysiology of Depression in Parkinson’s Disease

Depression is a debilitating nonmotor symptom of Parkinson’s disease (PD) that affects approximately 40% of patients and contributes to worsened quality of life. Despite its prevalence and burden, depression in PD is often inadequately treated with current therapies. Growing evidence indicates depression is likely linked to PD pathophysiology involving the basal ganglia, rather than just a reaction to general illness. Deep brain stimulation (DBS) therapy, targeted to the basal ganglia in either the globus pallidus internus (GPi) or the subthalamic nucleus (STN), is effective for improving PD motor symptoms. However, the effects of DBS on depression in PD vary across patients, from meaningful improvements to detrimental worsening. This variability is partly because the basal ganglia pathophysiology of depression is unclear, and it is unknown which brain signals and networks to modulate with DBS to improve depression in PD. The objective of this proposal is to identify basal ganglia neural activity associated with depression in PD and identify brain regions and networks associated with depression improvement with DBS in PD. My central hypothesis is that PD patients with depression exhibit altered neural activity compared to patients without depression, and these alterations (1) are localized to specific brain regions and networks, and (2) are similar across the GPi and STN, pointing to a common basal ganglia network associated with depression in PD. To investigate, I will use multimodal approaches combining neural recordings in patients who underwent GPi DBS or STN DBS for PD (N=199 patients, 291 hemispheres), neuroimaging to map brain regions and networks, and computational models to evaluate the effects of DBS. In Aim 1, I will identify basal ganglia neural activity associated with depression in PD using machine learning techniques. In Aim 2, I will determine the local and network topography of basal ganglia neural activity to identify physiological brain networks showing alterations in PD patients with versus without depression. In Aim 3, I will identify “hotspots” and brain networks associated with depression improvement with DBS for PD. During the K99 phase, I will receive training in human neurophysiology and clinical research in psychiatry, facilitated by Dr. Coralie de Hemptinne (expert in human neurophysiology), Dr. Gregory Pontone (expert in neuropsychiatry in PD), and a team of interdisciplinary advisors. After securing an independent faculty position, I will transition into the R00 phase and build on my K99 research in Aim 4 to prospectively evaluate neural activity and neuroimaging- based markers of depression in PD in a novel cohort (N=20 patients) using a DBS device capable of chronic neural recordings to test whether they correlate with longitudinal depression symptoms in the patients’ naturalistic environment and evaluate the effects of DBS and dopaminergic medication. Collectively, this K99/R00 award will enable me to pursue the technical and career development training necessary to prepare me to lead an independent research lab focused on understanding the pathophysiology of neurological and psychiatric disorders and establishing neurophysiological and network-guided neuromodulation therapies.

Public health relevance
Depression is a prominent neuropsychiatric symptom in Parkinson’s disease (PD) that contributes to worsened quality of life, but current treatments are often inadequate because the underlying pathophysiology is not well understood. Deep brain stimulation (DBS) targeted to the basal ganglia is an effective treatment for motor symptoms, but its effects on depression vary widely across individuals, partly because it is unclear how to tailor DBS to treat depression in PD effectively. This study will identify basal ganglia neural activity and brain networks implicated in depression in PD and develop multimodal approaches to tailor DBS to treat depression more effectively in order to improve the quality of life for patients with PD.